Advancing Clinical Research Training within Addiction Residency Programs

PROJECT SUMMARY
Fostering the next generation of multidisciplinary, clinician investigators in the field of addiction is critical for
preventing and addressing the ongoing impact of substance use disorders in the United States. Addiction
Medicine and Addiction Psychiatry physicians with clinical addiction expertise are a critical part of those
investigators needed to pursue important clinically-focused addiction research questions. In this renewal
application and building on our successes over the past 11 years, while responding to evolving needs in the
field, the Research in Addiction Medicine Scholars (RAMS) Program seeks to advance its mission to
strengthen the next generation of addiction physician researchers and leaders. Drawing from the North
American-based pool of fellows training in Addiction Medicine (n=96 programs) and Addiction Psychiatry (n=54
programs) and by supporting local mentorship, the RAMS Program will foster development of addiction-trained
clinician investigators and leaders. The RAMS leadership team in conjunction with the RAMS National
Advisory Committee (NAC), will provide the following: a combination of monthly webinars; leadership
development training; a multi-pronged diversity, equity, inclusion and belonging (DEIB) curriculum; harm
reduction training; and two annual intensive, in-person retreats (Fall retreat and Spring retreat [embedded in
the College on Problems of Drug Dependence (CPDD) national annual meeting]).
Together, the RAMS team and infrastructure will achieve the following Specific Aims:
1) Provide clinical research training over 2 years to 5 RAM Scholars (Addiction Medicine and Addiction
Psychiatry fellows), recruited annually, through retreats, webinars, and research-in-progress sessions.
2) Augment mentoring and networking of the RAM Scholars regarding research projects and career
trajectory, by establishing rigorous mentorship relationships between Scholars and nationally recognized
researchers (RAMS NAC) and through interactions between Scholars, RAMS alum, and RAMS core faculty.
3) Provide leadership training for the RAM Scholars, by introducing physicians to the concepts and skills
necessary for leading organizations.
4) Promote a culture that fosters diversity, equity, inclusion and belonging among and for RAM
Scholars and their institutional mentors which stimulates research focused on addressing the impact
of racial marginalization and its impact on substance use and related outcomes. The RAMS Program is
integrating a new multi-pronged curriculum devoted to promoting research and clinical interventions to undo
systems of bias and marginalization as related to substance use.
The RAMS Program will continue to be of high impact by accelerating the progress of its important goal of
developing the next generation of addiction physician researchers to advance the knowledge base to provide
better care for individuals with, and at risk for, substance use disorders.

Public health relevance
PROJECT NARRATIVE The Research in Addiction Medicine Scholars (RAMS) Program is significant because it engages trainees who are future clinical researchers and leaders in the expanding subspecialties of Addiction Medicine and Addiction Psychiatry. RAM Scholars’ research will seek to improve patient care; reduce the medical, social, and financial burden of individuals with substance use disorders; and promote equitable treatment and research.